Irradiator Shared Resource

IRRADIATOR SHARED RESOURCE – PROJECT SUMMARY/ABSTRACT
The Irradiator Shared Resource (ISR), formerly known as the Cesium-137 Irradiator Shared Resource, was
established in 1991 with a Cesium-137 gamma-ray irradiator to provide accurate, cost-effective, convenient, and
reliable access to ionizing radiation to Yale University investigators for irradiations of molecular compounds, cell
cultures, animal and human tumor cells, and whole animals. In 2022, the Yale Cancer Center (YCC) Shared
Resources Oversight Committee recommended the expansion of the Cesium-137 Irradiator Shared Resource
to include four additional kilovoltage x-ray irradiators and one advanced image-guided small animal research
irradiator (being installed in 2023) and name the expanded resource as Irradiator Shared Resource for the
coming funding cycle. The ISR will have six irradiators offering both gamma- and x-rays with a wide range of
dose rates, collimation, and controlled environment for delivering precise irradiations to biological or chemical
samples. It will continue to serve as an essential and comprehensive resource for YCC researchers who are
studying the effects of radiation on biological samples, animals, and cells in culture or are using radiation as part
of their experiments to create mutations for studying the biologic effect of radiation, or of mutations themselves,
or for immunosuppression. In the last 5 years, approximately 12 (and 34) YCC investigators per year have used
the Cs-137 (and x-ray) irradiators. During the most recent funding period (FY22), 10 (and 29) YCC Principal
Investigators used the Cs-137 (and x-ray) irradiators. Among the total irradiator usage, 86% (and 95%) of the
gamma-ray (and x-ray) use were by YCC members from four research programs. Most of the use came from
Cancer Immunology (CI) and Radiobiology & Genome Integrity (RGI) research programs, followed by the
Genomics, Genetics and Epigenetics (GGE) and Cancer Signaling Network (CSI) research programs. The
results from many basic research studies that involved the irradiators have enabled YCC physicians to improve
their ability to detect and treat cancer efficaciously. The overall objective of the ISR is to continue provide
centralized and comprehensive irradiation services to cancer researchers at YCC. The specific aims of the ISR
are: 1) Provide all YCC members with convenient and reliable access to state-of-the-art gamma-ray and
kilovoltage x-ray irradiators, with cost-effective irradiation services for all YCC members; 2) Provide expert
radiation physics and technical consultation to YCC members on the experimental design involving the gamma-
or x-ray irradiators; 3) Provide hands-on training for the staff of YCC members to ensure accurate, efficient, and
safe use of the irradiators at all times; and 4) Ensure irradiator availability of 24 hrs/day, 365 days/year to YCC
cancer investigator through proactive irradiator maintenance and quality assurance.

Public health relevance
IRRADIATOR SHARED RESOURCE – NARRATIVE Not applicable.